Chlamydia trachomatis evades a novel IL32-mediated immune resistance program

ABSTRACT
Chlamydia trachomatis (Ct) represents the most common sexually transmitted bacterium in the U.S., and
is responsible for severe sequelae such as pelvic inflammatory disease, ectopic pregnancy, and infertility. No
vaccine is currently available. Much of what makes Ct such an effective pathogen is its ability to evade the host
immune response. The molecular mechanisms of this immune evasion remain largely uncharacterized, and
represent a major gap in knowledge which is necessary for the proper prevention of this disease. Chlamydia
species invade host epithelial cells, where they establish infection within a membrane-bound vacuole called an
“inclusion”. At least two closely-related species of Chlamydia can infect human epithelial cells: C. trachomatis
(Ct) and C. muridarum (Cm). Once inside these epithelial cells, Cm is vulnerable to clearance by intracellular
defenses galvanized by interferon-γ (IFNγ), while Ct is able to expertly evade these defenses and will grow
uninhibited. These IFNγ-induced defenses, and their evasion by Ct, are poorly understood phenomena in need
of further research.
We recently discovered that a human IFNγ-stimulated gene (ISG) drives restriction of Cm through an
intracellular, proteasome-dependent mechanism. I also found that the Ct gene IncS confers protection against
this ISG. In the following proposal, I propose experiments to better understand how Ct IncS drives evasion of
human IFNγ-stimulated host defense. These experiments will include comparisons between Cm and Ct IncS
function, and will focus on the role of two host proteins recruited by Ct IncS: STIM1/2. Our hypothesis is that Ct
recruits STIM1/2 as a form of “molecular camouflage” to hide individual inclusions from host recognition and
immune clearance. I will also propose experiments to better understand how the proteasome defends against
Cm. I will perform several experiments to determine whether the proteasome directly localizes to Cm and if it
degrades bacterial proteins to clear Cm infection. I will also perform a proteomics screen to identify additional
protein partners involved in IFNγ-mediated restriction of Cm. Together, these experiments will provide a better
understanding of intracellular defenses within the human epithelium and will characterize a novel mechanism of
immune evasion by C. trachomatis. Through characterizing host-pathogen interactions during Chlamydia
infection, we hope to guide the design of improved options to prevent and treat chlamydial disease.

Public health relevance
PROJECT NARRATIVE Our lab works to understand epithelial cell-autonomous immune processes deployed against intracellular pathogens, and how these processes are evaded by human pathogens like Chlamydia trachomatis. This project aims to characterize a novel human anti-Chlamydia immune pathway and a specific Chlamydia trachomatis virulence factor that inactivates this pathway. It is hoped that these studies will inform future design of therapeutics and vaccines.